California Department of Food and Agriculture, Egg Safety and Quality Management Program application for Conformance with the Egg Regulatory Program Standards, Cooperative Agreement.

Project Summary
RFA-FD-22-006
The Department of Food and Agriculture (CDFA) supports the Egg Safety and Quality
Management (ESQM) program which is well positioned to participate in the Egg Regulatory
Program Standards (ERPS) implementation. The ESQM program was in the unique position of
being involved in the initial development of the ERPS, cooperatively, along with Iowa and the
U.S. Food and Drug Administration (FDA). This three-plus year comprehensive experience with
ERPS allows ESQM an excellent opportunity to continue and expand the work, while
maintaining consistency and enhancing the food safety and quality consumer product goals and
missions of CDFA and ESQM.
In congruity with the FDA’s desired outcomes under this Cooperative Agreement, ESQM is
dedicated to the ERPS goals to assess and build on the ESQM regulatory foundation, contribute
to the improvement of the ERPS, help develop and implement electronic information sharing
protocols, strengthen a foundation for pursuing regulatory actions and outbreak investigations,
improve the ESQM outreach and education for egg producers and maintain a commitment to
complete compliance and integration of the ERPS.
Through this funding opportunity, ESQM will hire an Environmental Scientist (ES) to complete
the ERPS Standards, which will entail a full self-assessment of the program and action plans for
making improvements to close the identifiable gaps. The ES would lead the ESQM program
through all the improvement plan steps to achieve full implementation. The Environmental
Scientist will work with the FDA to draft protocols and agreements in order to fulfill the goal of
electronic information sharing. These goals target the implementation, further improvement,
and promotion of the ERPS as a national integrated food safety system.

Public health relevance
Project Narrative RFA-FD-22-006 The mission of California Department of Food and Agriculture’s (CDFA) Egg Safety and Quality Management Program (ESQM) is to ensure that eggs sold in California are of known quality, origin, grade, and size and support the consumption of high quality, safe eggs. The implementation of the Egg Regulatory Program Standards (ERPS) will provide ESQM with a uniform plan to consistently evaluate and improve egg safety inspection programs to achieve the long-term goal of a sustainable standards program.